Improving the quality and value of primary health care

This research is currently just being started. This year's accomplishments include: developing collaboration with a practice based research and learning network, co-developing research project ideas and undertaking a review of the literature and environmental scan of resources unique to the NIH Intramural Research Program environment. Another accomplishment is the hiring of a postdoctoral fellow for the lab. Draft publications are underway.